Training Program in Biochemistry, Cell and Development Biology

PROJECT SUMMARY
This is a new application for a T32 to support predoctoral training in Biochemistry, Cell and Developmental
Biology (BCDB) at Emory University. The award will replace the current T32 training program, which is in its 29th
year, and has successfully trained a diverse cohort of students for the biomedical research workforce. We are
requesting 7 positions and anticipate the duration of appointment will be 12-24 months. The mission of the BCDB
training program is to provide an outstanding training environment through evidenced-based learning
approaches and top caliber research mentors for development of our Ph.D. level workforce in academic-,
industry- and government-based research careers as well as other biomedical research-related careers. This
mission will be accomplished through a core curriculum that includes discussion-based, active learning
approaches to the fundamental principles of biological processes at the biochemical and cellular level and
development of oral and written presentation skills through classroom and seminar experiences. In addition, the
importance of rigor and reproducibility in biomedical research is emphasized throughout the training with a
required course as well as emphasizing this training as part of the courses, seminars and journal clubs. The
objectives of the training program are to use these approaches to provide Ph.D. scientists with the necessary
skills in critical thinking, experimental design and quantitative approaches as they acquire an understanding of
how to conduct their work in a manner that is responsible, rigorous and reproducible. The program has an
inclusive environment and is active in the recruitment and retention of students from diverse backgrounds. There
is also an established focus on training the faculty mentors to provide the most outstanding training environment
possible. The program also provides unique training opportunities to students supported by the proposed T32
training program through their responsibilities in running an innovative journal club as well as their role in
organizing the two annual BCDB symposia; one which highlights career opportunities for Ph.D. graduates. We
plan to continue our track record of training success while also introducing new and innovative aspects to the
training together with mechanisms to evaluate both student and program outcomes.

Public health relevance
PROJECT NARRATIVE The new application requests funding to support predoctoral training in Biochemistry, Cell and Developmental Biology at Emory University. The proposal will replace the current, highly successful, training program that is currently in its 29th year, which had already incorporated quantitative training, evidenced-based learning approaches, formal scientific writing, training for faculty mentors and career/professional development. The new proposal builds on the strengths of the current program while adding new innovative approaches for enhancing training in rigor and reproducibility as well as novel methods for assessing student competencies in core areas important for the training of a diverse biomedical research workforce.